Role of a lactate-derived signaling metabolite in tissue crosstalk and energy balance

Project summary
The role of lactate in energy metabolism has been of considerable biochemical and physiologic interest. Beyond
its classical description as glycolytic end-product, lactate’s more recent emerging roles include inter-organ
metabolic fuel, receptor ligand, and protein post-translational modification. Given that some of these roles have
only been identified, or further expanded upon, in the past few years suggests that we are still in the early stages
of understanding the diversity of lactate functions in energy homeostasis. We have recently reported that lactate
metabolism into a downstream metabolite, Lac-Phe, generates a blood-borne signaling molecule that mediates
tissue crosstalk and suppresses feeding and obesity (Li et al., Nature 2022). Ablation of Lac-Phe biosynthesis
in mice increases food intake and obesity after exercise, demonstrating the physiologic relevance of this
pathway. Our data uncover an unexpected and underappreciated aspect of lactate – as a precursor for a
circulating lactate-derived signaling metabolite – in energy homeostasis. Because of this fundamentally new
insight, here in this proposal we focus entirely on additional biochemical and physiologic studies of Lac-Phe and
this downstream pathway of lactate metabolism. Building on a large body of published preliminary data, as well
as unpublished studies in cells and in mice, this proposal will test the central hypothesis that Lac-Phe is a tightly
regulated, lactate-derived signaling metabolite that engages specific cell surface molecules to regulate energy
balance. In Aim 1, we will determine the specific cell populations that produce Lac-Phe in vivo and their
contribution to whole-body energy balance. This Aim is enabled by our newly generated conditional, Cndp2
floxed allele which allows for cell type-specific ablation of Lac-Phe biosynthesis. In Aim 2, we will determine the
role of a kidney solute carrier in the downstream metabolism of Lac-Phe. Preliminary studies demonstrate this
solute carrier exhibits robust Lac-Phe transport activity in cells. Finally in Aim 3, we will determine the structural
features and downstream molecular targets that mediate Lac-Phe’s effects on food intake. We have identified
candidate cell surface molecules that are engaged by Lac-Phe. Successful completion of this proposal will
provide a detailed and molecular understanding of Lac-Phe biochemistry and physiology, thereby establishing a
scientific foundation for developing new therapeutics that target the Lac-Phe pathway for obesity, type 2
diabetes, and metabolic diseases.

Public health relevance
Project narrative. This project will dissect the role of an metabolite called Lac-Phe that suppresses body weight and obesity. This project will contribute fundamental knowledge about lactate biochemistry and the role of lactate-derived metabolites in tissue crosstalk and energy balance.